Peripheral Neurotrophic Factors in the Regulation of Adipose Tissue Energy Expenditure

In order to maintain proper energy balance and metabolic health, the body must tightly regulate the processes that control energy intake (appetite, food intake, nutrient absorption) as well as energy expenditure (physical activity, basal metabolism, thermogenesis). An important aspect of regulating energy expenditure is the transfer of signals from the brain through peripheral nerves to activate lipolysis and thermogenesis in white and brown adipose tissues, respectively. Cold-stimulation is able to increase the sympathetic innervation and activation of adipose tissues and thus increase energy expenditure through lipolysis and thermogenesis. The exact mechanisms by which cold (or other stimuli that increase energy expenditure) are able to mediate peripheral nerve plasticity are currently under-investigated and largely unclear. In the current project, we provide new evidence that white adipose tissue (WAT) undergoes increases in neural innervation after cold exposure or exercise in mice (plasticity), and reductions in neural innervation with aging or obesity/diabetes in mice and humans (neuropathy). In addition, we have demonstrated that adipose-resident immune cells are able to secrete the neurotrophic factor Brain Derived Neurotrophic Factor (BDNF), which we believe stimulates sympathetic nerve branching, neurite outgrowth, and synapse formation in order to stimulate energy-expending processes in adipose depots. Indeed, in models of adipose neuropathy such as aging, BDNF levels are significantly decreased in WAT. BDNF is well-studied in the brain, but has not been investigated for adipose tissue neurotrophic activity. We have found that BDNF is expressed in immune cells of the stromovascular fraction (SVF) of WAT, and that the secretion of BDNF increases after cold or noradrenergic stimulation. Deletion of BDNF from the myeloid lineage results in a striking and specific lack of neural innervation of adipose depots, without affecting other nerves in the brain, spinal column or neuromuscular junction. As a result of this `genetic denervation' we observed that the knock-out (KO) animals undergo a shift in energy balance that leads to increased adipose mass and lower energy expenditure, including a lack of UCP1 induction in WAT after cold exposure. We specifically hypothesize polarized macrophages in adipose tissue SVF act similarly to microglia in the brain — that is, they can be either immune cells that release nerve growth factors in response to injury or neuroplasticity needs, or they phagocytose neurites, leading to neuropathy. We have identified a population of macrophages we are calling cold-induced neuroimmune cells (CINCs) that we hypothesize secrete BDNF in response to cold/noradrenergic stimulation. In addition to investigating these mechanisms for adipose nerve plasticity and neuropathy, this project also seeks to better understand the types of nerves that innervate adipose as well as how proper innervation affects adipose tissue function, whole-body metabolism and the control of energy balance.

Public health relevance
Adipose tissue, or fat tissue, must communicate bi-directionally with the brain through the peripheral nervous system in order to properly function. Activity of the nerves that innervate adipose tissues is essential for appropriate metabolic control, but overall the types of adipose nerves and how they undergo changes are very poorly understood. This project seeks to investigate how peripheral nerves affect adipose tissue function, and how peripheral nerve plasticity is regulated by local nerve growth factors in the adipose tissue itself, with the goal of opening up a new field of adipose biology.